Role of lactate dehydrogenase A in endothelial metabolism and angiogenesis

The blood vascular system is an extensive network that provides tissues with oxygen, nutrients, and a variety of
angiocrine factors. It is formed mainly through angiogenesis, a process in which new blood vessels grow from
the existing vasculature. Angiogenesis is vital for embryonic development, tissue growth, and regeneration, and
is also involved in the pathogenesis of many human diseases. For example, proliferative diabetic retinopathy
(PDR) and retinopathy of prematurity (ROP) are eye disorders that may lead to vision loss in diabetic patients
and premature babies respectively. Both of these ocular diseases are characterized by excessive retinal
angiogenesis, which causes intravitreal hemorrhage, macular edema, and even retinal detachment. However,
current treatment strategies to inhibit aberrant blood vessel formation in PDR and ROP only have limited efficacy
and may elicit undesirable side effects. Therefore, understanding the mechanisms that drive blood vessel
formation is important because it may facilitate the development of better therapies for treating these severe eye
diseases. Formation of new blood vessels through angiogenesis involves proliferation, migration, and several
other energy-consuming endothelial cell (EC) behaviors. Recent studies have shown that proliferating ECs
preferentially convert glucose to lactate and generate ~85% of ATP through glycolysis rather than glucose
oxidation via the TCA cycle, even when the ECs are grown in an oxygen-rich environment. This metabolic feature
is also seen in cancer cells and is termed the Warburg effect. However, it remains unclear at the molecular level
why lactate instead of metabolites in the TCA cycle are favorably produced from glucose in proliferating ECs.
Pilot studies from the applicant’s lab suggest that lactate dehydrogenase A (LDHA), an enzyme catalyzing the
conversion of pyruvate to lactate and the regeneration of NAD+ from NADH, is a potentially key driver of the
Warburg effect in ECs. The central hypothesis of this application is that LDHA controls the metabolic fate of
glucose and sustains angiogenesis by regulating glycolytic flux in ECs. We will test this hypothesis through two
Specific Aims. Aim 1 will use various metabolic assays and endothelial-specific Ldha knockout mice to determine
the roles of LDHA in regulating the Warburg effect and developmental and pathological angiogenesis in the
retina. By combining mouse genetic models, molecular and biochemical approaches, and advanced analytical
tools, Aim 2 will identify the upstream regulator that controls LDHA expression in ECs and will elucidate the
mechanism by which LDHA regulates endothelial growth. Collectively, our proposal will advance the
understanding of the link between endothelial metabolism and blood vessel formation, and it will provide concrete
steps towards developing new strategies for inhibiting angiogenesis in human ocular diseases.